2024 Frontal Cortex Gordon Research Conference and Gordon Research Seminar

SUMMARY/ABSTRACT
The prefrontal cortex (PFC) is involved in all aspects of cognition and behavior and has established roles in all
forms of mental illness and substance use disorders. The PFC has been studied intensely over the past four
decades. Interest in studies of the PFC in animal models has grown at a pace equal to that of human studies on
the PFC. There are very few meetings that focus on the PFC and bring together researchers using different
animal models (non-human primates, rats, mice) and a variety of experimental approaches (e.g., lesions,
pharmacology, anatomy, physiology, molecular tools, computational models). A new Gordon Research
Conference (GRC) on the Frontal Cortex was established in 2022 to provide a forum for researchers interested
in the PFC and related cortical areas (e.g., OFC). This meeting was highly successful at developing a strong
community of scientists interested in discussing topics across disciplines, models, and techniques. The next
GRC will convene in Holderness, NH in August 2024. It is our hope that financial support can be obtained from
the NIH to build upon our successes and support the meeting. Support from NIH will allow us to offset the
attendance costs of our invited speakers and trainees, especially early career investigators and attendees from
underrepresented groups. We propose the following Aims: (1) To convene a diverse scientist workforce around
fundamental questions in research on the frontal cortex. The conference will feature panels on development,
circuit function, therapeutics, affect, cognitive control, and more, in keeping with the goal of connecting diverse
fields. (2) To unite a diverse scientist workforce around emerging technologies in frontal cortex research. Panels
will discuss the use of powerful tools such as optogenetics/chemogenetics, calcium imaging, computational
analyses, and more, and how they can be used to link studies in mice and rats to findings from studies in humans
and non-human primates. (3) To promote the development of women scientists, early-career researchers, and
under-represented investigators in frontal cortex research. In the service of this goal, we will support participation
from trainees and members of underrepresented groups, including providing financial support for attendance,
and we will host a networking and mentoring PowerHourTM focused on Imposter Phenomenon, Microaggressions
and Stereotype Threat.

Public health relevance
NARRATIVE The Gordon Research Conference (GRC) on the Frontal Cortex was established in 2022 to provide a forum for researchers interested in the prefrontal cortex, related parts of the frontal cortex and their functions across species. The frontal cortex regulates a wide range of behaviors and cognitive functions and is disrupted in numerous psychiatric and neurological diseases, necessitating an integrative, cross-topic platform to advance understanding of this complex brain system. For the 2024 meeting, we have planned a diverse meeting to include trainees and speakers from multiple research perspectives and career stages and have emphasized participation of under-represented groups.